Dermatology Consultation Service

The Consult Service Staff consists primarily of myself and a Nurse Practitioner, Olanda Hathaway, who joined the Branch in 2011. 3 Senior Investigators spend approximately 4 weeks/year Attending on the Consultation Service as well. As mentioned above, providing clinical expertise in the assessment and management of cutaneous disease is a highly valued service to the NIH community which was recognized by the NIH Director's Award in 2007. In addition to seeing patients in Consultation, I am an Associate Investigator on several dozen protocols initiated by other branches as well as a Principal Investigator on several therapeutic protocols (to be discussed separately). The chronic graft versus host disease (GVHD) collaborative effort is a major multidisciplinary collaboration with several NCI and non-NCI investigators studying the Natural history of GVHD. Based on my experience with this group, I have published several text chapters and clinical manuscripts on cutaneous GVHD and have been honored to lecture to various groups around the country (Harvard, Tufts, U. of Pennsylvania, the American Academy of Dermatology, regional dermatologic societies, and the World Congress of Dermatology.) Collaborative clinical research is extremely active via the busy consultation service.